Integrative Physiology of Thyroid Hormone Receptors and Nuclear Receptor Corepressors

Project Summary/Abstract
Thyroid hormone receptors (TRs) are nuclear receptors (NRs) that switch from transcriptional repressors to
activators in response to thyroid hormone (TH), a powerful regulator of lipid and energy metabolism.
Repression is mediated by NR corepressors NCOR1 and NCOR2/SMRT, which function in multiprotein
complexes containing histone deacetylase 3 (HDAC3), whose catalytic activity requires interaction with
NCOR1/2. This proposal focuses on mechanisms by which TH controls liver metabolism as well as non-
canonical metabolic functions of NCOR1/2 and HDAC3. Specific Aim 1 is to determine the molecular
mechanisms and role of thyroid hormone action in physiology and in non-alcoholic steatohepatitis
(NASH). TRb agonists have great promise in the treatment of NASH, but the mechanisms by which they
alleviate fatty liver, inflammation, and fibrosis are unclear. Preliminary data in mouse models demonstrate that
many TH-regulated genes are dysregulated in NASH livers, with evidence of both hypo- and hyperthyroidism.
We will use novel epitope-tagged TRb mice, functional genomics, and genomic region-specific proximity
labelling to determine the mechanisms by which TH-regulated genes are dysregulated in NASH. Our
preliminary data has also uncovered regulation of tryptophan (Trp) metabolism by both NASH and TH, and
shown that TH upregulates anti-inflammatory kynurenine (Kyn) metabolites downstream of Trp. We will use
metabolic flux analysis to understand these changes, and will determine the importance of Kyn metabolites in
the improvement of NASH by TH. Specific Aim 2 is to elucidate the physiological functions of nuclear
receptor corepressors in the liver. Preliminary data reveal that, in addition to repression of lipogenic genes,
NCORs unexpectedly activate gluconeogenic genes via an unrecognized chromatin opening ability. We
hypothesize that this is due to recruitment of chromatin remodelers, and will test this by utilizing a functional
genomics approach, including ChIP-seq, GRO-seq, and ATAC-seq combined with ChIP-mass spec in novel
mice with epitope-tagged NCORs. We will also use genomic region-specific proximity labelling to identify
proteins that interact specifically with NCORs at positively regulated genes. In addition we will determine the
mechanism underlying the regulation of gluconeogenesis by NCORs in the normal fasting response. Specific
Aim 3 is to determine the mechanisms underlying enzyme-independent functions of HDAC3 in the liver.
In liver, catalytically inactive HDAC3 can repress de novo lipogenesis and prevent hepatosteatosis, but the
mechanisms are not known. We will test the hypothesis that this is due to novel protein interactions by
combining functional genomics and proteomics using tagged wild type and mutant HDAC3. These innovative
studies address major questions regarding the mechanisms of action of TRs, corepressors, and HDAC3 and
will shed new light on the transcriptional and epigenomic control of metabolism in physiology as well as NASH
and related metabolic disorders.

Public health relevance
Project Narrative Thyroid hormone (TH) uses nuclear receptors (NRs) and NR corepressors (NCORs) to regulate all aspects of metabolism, especially in the liver where non-alcoholic steatotic hepatitis (NASH) in the setting of obesity and diabetes can be life threatening. We have uncovered novel aspects of how TH and NCORs regulate metabolism in the liver, and our studies will provide new insights into how normal metabolic physiology is regulated, and how TH alleviates NASH. This work is critical to understand and combat the metabolic abnormalities contributing to the epidemics of diabetes, obesity, and metabolic liver disease in the United States and worldwide.